Mount Sinai Medical Scientist Training Program

The mission of the Medical Scientist Training Program at the Icahn School of Medicine at Mount Sinai is to
educate a diverse cadre of future physician-scientists in a rigorous, integrated dual degree program that prepares
them to contribute to the improvement of human health through careers in a variety of clinical specialties and
biomedical research environments. The program features an inclusive and collaborative environment that fosters
innovation in fundamental and translational biomedical research. Our accomplished student body is selected
from a highly qualified and diverse applicant pool of students from all backgrounds who come with significant
prior research experience. Trainee retention has been high and attrition low, with average time to degree of 8
years. Intentional changes in our admissions and recruitment practices, including a more holistic review and
increased acceptance target numbers for women and students in other under-represented groups, have already
resulted in their increased representation among matriculants of the past five years and in the larger MSTP. The
proposed program includes a significantly increased level of institutional support, reflected in increased faculty
effort and staffing to direct the MSTP and increased financial support (with a separate program budget) for
student training and other activities that promote esprit de corps and the development of a physician-scientist
identity; a well-integrated curriculum that focuses on the experimental basis of scientific knowledge and on its
translational applications; increased use of team building activities; innovative graduate school curriculum that
incorporates a strong emphasis on development of quantitative and computational skills, entrepreneurship,
emerging technologies such as artificial intelligence, and training in rigorous and reproducible research design
throughout the program; increased attention to the transition from preclinical to PhD training and continued
improvements in a longstanding course that promotes a smooth transition to clinical training; strengthened
partnerships with pipeline programs to enhance the diversity of the MSTP student population and to provide
alternative pathways into the program from the medical school; MSTP student eligibility for early assurance
research track residency programs at Mount Sinai; and improved mentor training and mechanisms for monitoring
student progress and satisfaction. Our short- and intermediate-term goals are to provide an inclusive and diverse
training environment that will allow our students to continue to achieve at a high level and to equal if not surpass
the achievements of students of the past 5 years, as measured by publications, receipt of independent fellowship
support, and matching in top residency programs. While a large percentage of our alumni (82%) pursue basic,
translational, and/or clinical research in academic, pharmaceutical, biotechnology, and federal agencies, our
long-term goal is for more of our graduates to become independent investigators and leaders who address
important research questions related to human health and disease and translate their discoveries into strategies
for the prevention and therapy of disease in all communities and in an expanded array of career sectors.

Public health relevance
The Medical Scientist Training Program (MSTP) at the Icahn School of Medicine at Mount Sinai seeks to educate a diverse group of students from all backgrounds in a supportive, inclusive, and rigorous integrated dual degree training environment, within the large Mount Sinai Health System, that will ensure the success of their future careers as physician-scientists. Our leadership is committed to the education of forward thinking trainees who are passionate about biomedical research, improvement of human healthcare, collaborative problem solving, and social advocacy and justice and who will develop into independent and resilient investigators and leaders in translational medicine.